ACOUSTIC CHIASM--ANATOMY AND BEHAVIOR

Ablation behavior experimentation on the hindbrain auditory system has led to the conclusion that the superior olivary complex (or SOC) in the medulla may serve the auditory system as an "acoustic chiasm". The primary evidence is that unilateral lesions in the auditory pathway anywhere below this structure (that, in the cochlea, cochlear nucleus, trapezoid body) result in sound localization deficits either in both hemifields of auditory space or in the hemifield ipsilateral to the lesion. In sharp contrast, unilateral lesions in the pathway anywhere above the SOC (that is, in the lateral lemniscus or beyond) result in sound localization deficits only in the hemifield contralateral to the lesion. Therefore, there is a clear functional parallel between the SOC and the optic chiasm even though there is no obvious anatomical parallel. We propose to continue studying the anatomical and neurochemical basis and the functional consequences of this chiasm-like process in a series of tract-tracing, 2-DG, transmitter-identification, and ablation-behavior experiments in cats. In the new project period we will focus much of our early effort on the efferent projections of LSO and then on the afferents and efferents of DLL. Because the project entails rigorous psychophysical tests of sound localization capacities before and after selective hindbrain tract- sections or nuclear ablations, we hope the research will contribute to the understanding of auditory dysfunction in humans.